Micro-TeACH (Microbiome Technology and Analytic Center Hub)

ABSTRACT
Despite many advances in the field, the pathogenesis of autoimmune and immune-mediated diseases
(AIMDs) remains incompletely understood but appears to be multifactorial; genetic and environmental factors
are implicated in the aberrant inflammatory responses in many AIMDs, including lupus, rheumatoid arthritis (RA),
psoriatic spectrum diseases (PSD) and Sjogren’s syndrome (SS). Among potential triggers for these disorders
is the human microbiome, the communities of microorganisms that inhabit most body sites and surfaces.
Perturbations in the the skin, oral and gut microbiome are known to induce host immune cell activation,
downstream inflammation, and persistent tissue damage, contributing to the development of various AIMDs.
The last three decades have also witnessed fundamental advances in AIMD therapeutics. For example,
the use of methotrexate and subsequent incorporation of biologic treatments has led to substantial improvements
in RA and PSD clinical outcomes, enhancing the quality of life for millions of patients. However, despite this
progress a significant question remains unanswered: why do over 50% of patients with moderate to severe
disease fail to respond appropriately to these agents? Pharmacomicrobiomics – an emerging field of study that
investigates the effects of variations of the human gut microbiome on drugs – promises to overcome these
barriers and facilitate precision medicine approaches in AIMDs. Further, studying the microbiome in the
context of the AMP-AIM Network’s goal of disease reconstruction through high dimensional analytics of
tissue biopsies and samples will create a unique opportunity to incorporate potential triggers of immune activation
and predictors of drug response.
With a multidisciplinary team composed of computational biologists, rheumatologists, geneticists, and
microbiome researchers, we propose the creation of Micro-TeACH (Microbiome Technology and Analytic
Center Hub), a formal expansion of a longstanding NYC-based collaboration between Drs. Scher, Heguy (NYU
Grossman School of Medicine) and Clemente (Mount Sinai School of Medicine) that will integrate expertise in
AIMDs (RA, PSD and inflammatory bowel disease), extensive and well-phenotyped biosamples, and state-of-
the-art microbiomics methods to AMP AIM with the ultimate goals of: 1) identifying microbes and microbial
pathways as potential determinants of disease pathogenesis; 2) interrogating host-microbe spatial
interactions in affected tissues; and 3) discovering microbiome-based precision medicine approaches.
To achieve these goals, we will utilize the unique resources available to our groups and integrate our
software pipelines, microbiomics expertise, and data/metadata with biosamples and data accrued by all AMP
AIM Disease Teams, Technology and Analytic Cores, System Biology Cores and Knowledge Portal. This
approach should elevate the overarching aim of the AMP AIM Program, which seeks to gain a comprehensive
understanding of molecular and cellular disease pathways and to identify novel targets for intervention.

Public health relevance
NARRATIVE Despite remarkable advances in the immunopathogenesis of autoimmune and immune mediated diseases (AIMDs), the environmental factors that orchestrate the initiation and perpetuation of these disorders or determine therapeutic responses remain to be fully elucidated. Chief among them is the human microbiome, which has long been shown to contribute to inflammatory diseases. Successful completion of our proposed studies will provide key insights into the pathogenesis of AIMDs by interrogating (a) if the gut, skin and oral microbiome contribute to the initial inflammatory events in AIMDs, and (b) whether the gut microbiome can serve as a modulator of therapeutic responses to currently available drugs, ultimately identifying patients that are more likely to experience clinical improvement prior to treatment initiation.